Single-cell analysis of aging-associated 4D nucleome in the human hippocampus

PROJECT SUMMARY/ABSTRACT
See Project Summary/Abstract attachment for parent grant U01DA052769. The activities proposed in this
supplement application do not propose any changes to that attachment.

Public health relevance
PROJECT NARRATIVE See Project Narrative attachment for parent grant U01DA052769. The activities proposed in this supplement application do not propose any changes to that attachment.